Multidisciplinary Training in Neuroscience

PROJECT SUMMARY
This project would continue support for the Multidisciplinary Training Program in Neuroscience at Oregon
Health and Science University (OHSU) in Portland. The program, which is entering its 25th year, provides
broad, early stage training for graduate students entering the Neuroscience Graduate Program (NGP). The
NGP is based within the Vollum Institute, but includes faculty and students in many centers, departments, and
institutes on the OHSU campus. The program includes 61 students including the incoming class (ca. 10-12 per
year). Our training faculty of 44 scientists offers thesis research opportunities that include all levels of modern
neuroscience research from state-of-the-art cryoEM studies of membrane proteins and protein complexes to
systems neuroscience to disease-oriented and translational neuroscience. The recruitment of new faculty has
brought new areas of expertise that supplement the ongoing research strengths in the NGP. The program has
a number of unique strengths and innovative features as fully outlined in the proposal. This aspect is
highlighted by the creation since the last renewal of a Racial Equity and Inclusion Center that works specifically
and solely with NGP and Vollum trainees and faculty, accompanied by a dramatic increase in the diversity of
students in the program. Programmatic innovations include a unique core curriculum structure that begins in
the first year with a six-week long session of didactic and practical lectures and workshops that provide a
strong educational and community building foundation for the start of graduate studies. This is followed by a
12-week intensive course that provides a broad foundation in neuroscience for all students in the program.
This curriculum format allows first-year students to engage in fulltime laboratory rotations within four months of
matriculation. The core curriculum is supplemented by workshops and individual instruction in specific
techniques as well as professional skills, ethics, and career planning. At all levels of training, emphasis is
placed on fostering skills in experimental design, programming, and quantitative approaches so that trainees
become experts in scientific methodology and rigor. The spirit among the large neuroscience community at
OHSU, numbering approximately 140 affiliated scientists, combined with the broad scope of many research
institutes and the close proximity of basic and clinical research facilities, provide an outstanding environment
for early stage pre-doctoral students to establish and benefit from cross-disciplinary collaborations. This
foundation will foster the skills necessary for graduates to be successful in a full range of science-related
careers.

Public health relevance
PROJECT NARRATIVE The proposed training plan will educate early stage graduate students in the broad and interdisciplinary field of neuroscience. The program includes didactic coursework, training in critical thinking, experimental design and analysis, rigorous evaluation of laboratory research, and sustained experience in experimental science as well as training in personal and professional ethics, professional skill development, and career planning, all leading to a doctoral degree in neuroscience. Training takes place in an academic medical center environment with both fundamental basic research and translational and clinical research, allowing us to prepare trainees both intellectually and technically to become the next generation of neuroscientists, which is critical to the understanding and treatment of neuropsychiatric disorders.